Biostatistics and Quantitative Sciences Shared Resource

BIOSTATISTICS AND QUANTITATIVE SCIENCES SHARED RESOURCE: ABSTRACT
Biostatistics and Quantitative Sciences Shared Resource (BQS-SR) is a University of Florida Health Cancer
Center (UFHCC) managed shared resource whose objective is to provide UFHCC members with a centralized
resource for biostatistics, bioinformatics, computational biology, clinical trial support, and expertise in quantitative
science to ensure scientific rigor in cancer research. The BQS-SR meets this objective by providing
interdisciplinary collaborative support to members across the 3 research programs at all stages of their research.
BQS-SR assists with experimental design, sample size and power evaluation, randomization and stratification
procedures, study execution, data analysis, and publication of new findings in the understanding, prevention,
and treatment of cancer. The BQS-SR is directed by Lee (CCPS), with >20 years of experience as a member or
leader of a biostatistical shared resource at NCI-Designated Cancer Centers, with support from Unit Leaders for
bioinformatics and computational biology, clinical trials, and statistical genomics. BQS-SR is staffed by 12
personnel (a total of 7.5 UFHCC-supported FTE), comprised of 4 Biostatistics faculty, 1 Bioinformatics faculty, 5
Biostatistics staff scientists, and 2 Bioinformatics staff scientists. Additionally, BQS-SR serves as a liaison and
matchmaker between existing campus-wide specialized quantitative scientists and UFHCC members to support
specialized needs of externally funded cancer research projects. BQS-SR faculty are aligned to each of the
Research Programs and Disease Site Groups to ensure ready accessibility to UFHCC members. BQS-SR
promotes rigor and reproducibility by collaborating with and educating investigators, trainees, and research staff
through seminars, individual sessions, and short courses tailored to cancer researchers. BQS-SR ensures the
integrity of clinical research by participating in the IIT Think Tank, Scientific Review and Monitoring Committee
(SRMC), and the Data Integrity and Safety Committee (DISC). The BQS-SR advances quantitative science by
developing new methodologies including novel microbiome data analysis approaches and visualization for
single-cell RNA-Seq data. Since 2016, BQS-SR members supported 222 unique UFHCC users (138 with peer-
reviewed funding) through 286 grant submissions and reviewed 411 interventional clinical trial protocols through
the SRMC and DISC. Since reorganized by Lee in 2018, the BQS-SR has received 320 support requests from
113 unique UFHCC members, with ~34% related to grant proposals, 28% for IIT development, and 20% for data
analysis supporting peer-reviewed publications. BQS-SR members were co-authors on 340 cancer-relevant
peer-reviewed publications 15% with IF ≥10. In alignment with the UFHCC strategic plan, Momentum 2027, the
BQS-SR future plans include implementing expanded group-randomized trial designs for cancer health equity
and disparities studies, developing novel graphical approaches/statistical methods for single-cell RNA-Seq data
analysis, and leading the application of innovative artificial intelligence-based machine learning/deep learning
for diagnostic, prognostic, and prediction model development in cancer research.